"Novel Mouse Models for Quantitative Understanding of Baseline and Therapy-Driven Evolution of Prostate Cancer Metastasis"

PROJECT SUMMARY / ABSTRACT
On average, a man dies from PCa every 16 minutes, mainly due to development of secondary malignant
growths outside of the primary cancer site, known as metastases. The cornerstone of PCa treatment is
androgen deprivation therapy (ADT). ADT temporarily halts PCa, but leads to resistance in nearly all cases,
resulting in castration-resistant PC (CRPC). CRPC then undergoes further evolution of metastatic subclones
and results in incurable disease. Research techniques revealing resistance mechanisms and clonal evolution
of metastatic PCa are lacking due to the limited capacity of current animal models to mimic PCa evolution in its
native microenvironment as well as inefﬁcient methods for tracing subclonal evolution.
Therefore, we developed EvoCaP (!Evolution in Cancer of the Prostate”), a mouse model of endogenous
metastasis that recapitulates human PCa genetically, by using PTEN/TP53 co-deletions enriched in metastatic
patients, and phenotypically, by focal initiation of primary disease progressing to bones, lungs, lymph nodes
and liver metastases. Our model uses a lentiviral platform - LV.CreBC10 carrying: (1) Cre (Pten/Trp53 co-
deletions; activation of Cas9, ﬂuorescence and luminescence markers); (2) Barcode with ten sites for marking
by Cas9 (BC10); (3) RNA guide speciﬁcally marking BC10; and (4) guide or short hairpin RNA for testing
metastatic drivers. Luminescence (FLuc) permits continuous tracking of disease progression and ﬂuorescence
(eGFP) allows for speciﬁc sorting of cancer cells. BC10 represents a synthetic array of on-target sites, in order
of decreasing activity, for the RNA guide that attracts Cas9 to generate subsequently speciﬁc edits. To
streamline barcode analysis, we have established an R package - EvoTraceR. This comprehensive system
enables: (1) the proﬁling of cancer cells based on shared mutational patterns in primary and metastasis; and
(2) the building of phylogenetic trees to track evolution toward metastases in a robust and ﬂexible way.
Our central hypothesis is that differences in distinct molecular and phenotypical clonal architectures will be
precisely detected between primary and metastatic sites depending on therapy status, enabling the inhibition of
metastasis and/or resistance promoting genes and pathways. Our analyses will establish and mechanistically
validate drivers of metastatic clonal expansion caused by Pten/Tp53-loss (basal) and also investigate how
evolutionary pressure from therapy (ADT), applied at different stages of PCa, leads to the emergence of
resistant clones. We will then use Cas9/guide (g)RNA and inducible short hairpins to target genes altered in
those expanding clones to identify drivers of both treatment-naive and treatment-induced PCa metastasis.
EvoCaP can feasibly track molecular evolution and validate targets for drug development, which may lead to
identiﬁcation of novel metastatic driver genes and pathways. Thus, therapies could be applied in: (1) primary
diseases for early detection and interruption of metastases development; and (2) already existing metastases.
Importantly, technologies developed in this project can also be applied to other types of metastatic cancers.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to advance public health by improving the very poor survival rate of patients with prostate cancer (PCa) due to the presence of metastases and no available curative therapies. Our research will identify alterations causing PCa to spread to other tissues by tracking the metastatic clones as they develop using our new model system, EvoCaP, both in the presence and absence of standard therapy. By identifying genes and pathways that cause PCa to spread and colonize different organs, our project is designed to ﬁnd new, vital drug targets previously missed by traditional methods of identiﬁcation, to treat advanced forms of metastatic PCa.